High-resolution single cell profiling of vaccine responsiveness in the elderly

PROJECT SUMMARY
The goal of this project is to understand the aging-related genomic and functional changes in immune
cells that affect responses to flu vaccination. The declining ability of the aging immune system to mount
protective responses to vaccines is a major threat to the health, independence and survival of older adults. Much
knowledge into the mechanisms of this decline has been gained from studies focused on one or a few immune
cell subsets, or on bulk transcriptomics. However, this work has not produced two critical pieces of information:
1) an integrated view of the collective changes across relevant immune cell populations with aging, and 2) the
ability to link specific immune cell subsets with their underlying cellular phenotypes/transcriptional profiles, and
to compare these phenotypes and profiles as a function of age and responsiveness to vaccines. Single cell
profiling, a term we use to encompass flow and mass cytometry together with single cell RNAseq (scRNAseq),
is uniquely positioned to deconvolve immune system heterogeneity and identify novel distinct immune cell
subsets in health and disease. Single cell profiling will therefore enable us to resolve the immune cell subset
deficits relevant to the elderly immune response to vaccines from PBMCs, a highly heterogeneous starting
population of cells, but one that offers the advantages of being clinically accessible, highly representative and
ultimately unbiased for the purposes of data generation and analysis. We have shown that we can identify
discreet cell-type-specific immune signatures of aging from PBMCs, even when such immune subsets represent
a small fraction of the total PBMC pool, and have preliminary single cell profiling data from elderly PBMCs,
underscoring feasibility. Here, we will analyze PBMCs at the single cell level from elderly donors before and
after vaccination (Aim 1), and with or without in vitro activation of specific immune subsets (Aim 2), to understand
the coordinated transcriptional and functional changes that occur, or fail to, as a function of age and vaccine
responsiveness. This proposal builds on our recognized expertise in human immunology and incorporates
essential expertise in cytometry and single cell transcriptomic analysis (JAX-GM), and access to elderly cohorts
(George Kuchel, UConn Center on Aging). Impact: These studies will yield, with unprecedented resolution, the
cell-type-specific immune signatures that distinguish responders to flu vaccine from non-responders, and will
provide critical clues into the mechanisms and biomarkers of a successful vaccine immune response.
Furthermore, these studies will generate a considerable amount of transcriptional and functional data related to
the outputs of key innate immune and T/B-cell subsets involved in the influenza vaccine response of elderly
individuals. The data will be an important resource for future studies of the elderly immune system in health and
disease.

Public health relevance
PROJECT NARRATIVE The vulnerability of elderly individuals to infection with influenza, even among those who have been vaccinated, is a serious public health issue. This proposal seeks to pinpoint the cell types and molecular “signatures” that distinguish those who mount protective immune responses to flu vaccine from those who do not. Such information could help researchers to design more effective vaccines in the future.